Role of novel VTA neurons in addiction-related behaviors

PROJECT SUMMARY
Thveenttreaglmeanrtea(alVTiAsa)corceomponoeftnhtneeurcailrctuhidatrtriygvoe-asdlirebcetheadvior
andaprimtaarrygtehtrowuhgihcdhruogfsabusmeodulbaetheavAilotrh.oguegnherraelglayradsaed
dopaminneurcglieacubsoh,uatolfVTAneursoingstnharlorueglheoaftsheaeminaocindeurotransmi
GABaAngdlutaTmhaetnsee.uraornaeslstoargoefdtrsuogfasbubsuemtuclhesstudRieecde.envtidence
froomulraabndothehrasbsegutnoshotwhalti,VkTeADAneuroancst,iivnViTtAGyABAandglutamat
neurcoanpnsrofosuhnadmploeytivbaetheadvFiuortsh.esrumbo-rpeo,puolfVaTtAnieounrsroenlsemaosree
thaonneofthetsherreeecycling neurtohncsaot-reldeopaasmeaindelutamoarte,
transmitters, including
glutaamnaGdtAeBAT.hgeoaolftshpirsopoasrtaeoildenhtoiwtfryanscmiot-trefrlreoaVmsTeAcontribut
tothperoceusnsdeesrbleyhianvgrieoirnaflonrtac,nehdmoewco-relneeausrifonungnsctiionntaelgilrnyattoe
thmeesolinmebuirccailrctuhiratetsgumloattievbaetheadvWieowriu.lslaenarroafgyeneatpipcroaicnhes
combinwaittibhoenhaviaonraatlo,maincdealle,ctrophyassisoailynomsgiictceoaslelectpirvoebtlehye
connecatnidfvuintcytoifdoinscVrTeAtceircuits.thicsntinruisnegarch cpormopgrriaasmes
Together
thoropulgathnodeftihnfeoramnfduncotfnioovncellasosfVeTsAneuraonedsnhanocuuernderstand
ofhowintrViTnAhseitcerogsehnaepbieetshyaviorstoneuropsydcihsieaatsrei.c
relevant

Public health relevance
PROJECT NARRATIVE Achieving a better understanding of the neural circuitry that control motivated behavior is critical to developing new strategies to treat and prevent drug addicition and other compulsive disorders. Dopamine neurons in the VTA have been widely implicated as a common substrate of drugs of abuse, but other VTA neuron types also contribute and may represent new targets for future intervention. This continuing research program will evaluate the contribution of novel populations of VTA neurons that release and co-release glutamate to behavioral reinforcement and other processes that underlie addictions.